Developmental Research Program

Project Summary/Abstract – Developmental Research Program
The availability of mature projects of potentially high translational impact forms the cornerstone of any
successful SPORE. The Developmental Research Program (DRP) of the Fred Hutch Lung SPORE will ensure
that such projects are always available for inclusion in future iterations of the SPORE or as replacements for
faltering projects. To accomplish this, we have assembled a DRP Committee that includes a broad array of
research expertise as pertains to lung cancer. Dr. Houghton and Dr. Lampe, both SPORE project PIs will serve
as the Chair and Co-Chair respectively. Both Dr. Houghton and Dr. Lampe serve on the Executive Committee
as well, which will ensure effective communication with SPORE leadership, as the development of new
projects is such an essential requirement for programmatic success. In conjunction with appropriate
administrative support, the DRP Committee will solicit applications and select the most highly meritorious
proposals for funding. Each DRP Awardee will be integrated into the Lung SPORE, and gain access to all
SPORE core facilities. Importantly, SPORE investigators will ensure that all DRP Awardees identify necessary
collaborators for the successful completion of the project and for guidance to reach putative translational
endpoints.

Public health relevance
Project Narrative – Developmental Research Program The Fred Hutch Lung SPORE Developmental Research Program (CEP) will identify and fund pilot project proposals from talented investigators engaged in highly innovative and potentially impactful research; this will be accomplished by assembling a DRP Committee composed of a broad area of research expertise that is strategically located throughout our greater institution to ensure optimal outreach efforts with respect to solicitation. In conjunction with administrative resources, the DRP Committee will solicit applications, conduct a rigorous and fair review process, select superior applicants to receive financial and other SPORE support, and ensure adequate collaborative opportunities and follow-up in the post-award phase. Continued support and development of promising research projects will be focus of the SPORE to ensure that mature projects capable of becoming new projects in the future or replacing current SPORE renewals are continuously available.